Phase II Clinical Trial to Evaluate a Vaccine Candidate for Gonorrhea (Meningococcal Immunization Against Gonococcal Infection)

To support a phase II randomized, placebo-controlled study, to assess efficacy of a vaccine candidate to prevent gonococcal infection, which could help avoid possible antibacterial resistance issues associated with gonorrhea.